PREDICTIVE VALUE OF LIPOPROTEIN (A) HOMOCYSTEINE AND EBCT IN DIALYSIS PATIENTS

The purpose of this study is to evaluate factors related to heart disease in dialysis patients. To do this we are going to assess calcified atherosclerotic plaque build up in the blood vessels of the heart using a specialized CT scan as well as blood tests for factors associated with heart disease.